Identifying mechanisms of immune dysregulation via severe pediatric SARS-CoV-2

Project Summary/Abstract
This proposal presents a five year research career development program focused on the mechanisms by
which a dysregulated adaptive immune response to SARS-CoV-2 infection leads particular children to become
critically ill. The candidate is currently a Pediatric Critical Care Medicine (PCCM) clinical fellow at the University
of California, San Francisco (UCSF) and has been appointed Assistant Professor of Pediatrics at UCSF
beginning July 1, 2024. The outlined proposal builds on the candidate's previous research and clinical
experience caring for, and studying, children with multisystem inflammatory syndrome in children (MIS-C), a
severe and enigmatic post-SARS-CoV-2 inflammatory disease. It integrates the synergistic expertise of co-
mentors Joseph DeRisi and Mark Anderson in state-of-the-art functional genomic technologies for immune
profiling and mechanisms of autoimmune disease. The proposed experiments and training will position the
candidate with a unique set of cross disciplinary skills that will enable his transition to independence as a
physician scientist studying mechanisms of immune dysregulation in pediatric critical illness.
Immune dysregulation is increasingly recognized as underlying a wide range of critical illness in children.
Efforts to treat these conditions are limited by a lack of diagnostic clarity or targeted therapies, underpinned by
gaps in knowledge of the specific mechanisms by which infections precipitate immune dysregulation. Previous
work studying adults with COVID19 revealed that unrecognized autoantibodies predispose certain individuals
to critical illness. However, in part because severe pediatric SARS-CoV-2 related disease is so rare, a detailed
mechanistic understanding of what causes certain children to be particularly vulnerable remains lacking. The
foundation of this proposal are preliminary studies which leveraged state-of-the-art technologies to identify a
set of novel autoantibodies specific to children with MIS-C, and the related discovery of cross-reactive B and T
cells between SARS-CoV-2 and the antiviral host protein SNX8. Whether additional novel autoantibodies
contribute to a wider range of severe pediatric SARS-CoV-2 related diseases, and how cross-reactive adaptive
immune responses lead to MIS-C, are questions addressed in this proposal. The aims are: 1) Define and
characterize the autoantibody repertoire in children with severe SARS-CoV-2 disease and, 2) Determine the
biological consequences of cross-reactivity in MIS-C. The scientific objective of this proposal is to elucidate
specific mechanisms by which certain children, either by harboring pre-existing autoantibodies or generating
cross-reactive adaptive immune responses, develop critical illness from common infections. The results will
inform subsequent studies: a) establishing pathogenicity of these autoreactivities through organoid and murine
models, b) building diagnostics to identify vulnerable children and targeted therapies to treat them, and c)
translation of the immune profiling platform developed in this proposal into additional disease contexts.

Public health relevance
Project Narrative Immune dysregulation underlies many forms of pediatric critical illness, including severe manifestations of SARS-CoV-2 infection. Efforts to effectively identify and treat children with infection-related immune dysregulation have been hindered by gaps in knowledge of the mechanisms connecting pathogen exposure to severe disease. This proposal leverages state-of-the-art immune profiling technologies and a unique cohort of children with life-threatening manifestations of SARS-CoV-2 to elucidate some of these mechanisms, towards improved outcomes for children particularly vulnerable to common infections.